CLINICAL INVESTIGATION SECTION

The Clinical Investigation Section of the NMOB is charged with maintaining vigorous clinical research activities and with sustaining educational programs for fellows, nurses, pharmacy, and other clinical staff. - Human Subjects & Human Tissues, Fluids, Cells, etc.